Integration of Actin Dynamics and Adhesion in Cell Migration

Project: CDK-1-mediated phase dissolution of Tensin1 condensates contributes to focal adhesion disassembly at mitosis to relieve an integrin inactivation G2-M checkpoint.
Personnel: Ana Pasapera, Hrishika Gogeni
Goal: Test the hypothesis that mitotic cell rounding is mediated by reducing cell-ECM adhesion through timely regulation of focal adhesion (FA) proteins by mitotic promoting factors.
We found that cell de-adhesion is an early prophase event that occurs perfectly coincidentally with mitotic cell rounding and cyclin B nuclear translocation, and is accompanied by a rapid drop in traction forces with no apparent pre-de-adhesion peak. Taken together, our data suggest that the mitotic-promoting factor CDK1 regulates cell de-adhesion at mitosis by mediating massive phosphorylation of the integrin-actin linker, tensin 1 in its IDR. This phosphorylation potentially drives the dissolution of tensin 1-containing biomolecular condensates and tensin 1 early removal from FA, leading to integrin inactivation and FA disassembly. Our data further suggest that cell de-adhesion at mitosis is a checkpoint required for cell cycle progression in adherent cells. We are right this very second making non-phosphorylatable and phosphomimetic tensin 1 variants with all the Ss and Ts in the IDR mutated to see if the phosphorylation is required for dissolution of the droplets, and if dissolution of droplets is required for FA disassembly at mitosis and for cell cycle progression.
Project: Role of ezrin in ECM stiffness sensing. Zbyszek Baster is working on the role of ezrin, radixin and moesin family (ERM) proteins in cell mechnosensation. ERMs are the main proteins linking the actin cortex to the cell plasma membrane118. ERM protein activity is regulated through their N-terminal binding to PIP2 rich plasma membranes followed by their phosphorylation at T567/T564/T558 (ezrin/radixin/moesin, respectively) by the homologous kinases, LOK or SLK, or by the Rho/ROCK pathway, to promote binding of the ERM C-terminal domains to actin119121. Activation of ERMs thus drives cortex-membrane tethering, which serves as one means of increasing cell stiffness and surface tension122. Since it is well established that mechanosensing of stiff ECM causes cell cortical stiffening89,122,123, it seems sort of shocking that little is known about whether ERM proteins are regulated in response to different mechanical stimuli. Zbyszek will thus test the hypothesis that cells respond to mechanical parameters of their environment in an ERM-dependent manner, and will dissect the signaling pathway mediating that response. He will use polyacrylamide or silicone cell culture substrates of a defined Young modulus and the Strex cell stretcher we plan to buy. ERM expression, activation and distribution will be analyzed in fibroblasts using molecular biology- and light microscopy-based techniques. ERM proteins and known ERM regulation or mechanotransduction pathways will be inhibited or stimulated using drug and gene expression manipulations to find molecular mechanisms by which ERM mechanosensation and mechanoresponse are mediated. Cell mechanical properties will be measured by AFM. This study will elucidate the mechanism of stiffness-dependent control of cell mechanical properties.